Advancing Science, Practice, Programming and Policy in Research Translation for Children's Environment Health (Asp3ire)

ADMINISTRATIVE CORE (AC)
PROJECT SUMMARY
The Administrative Core (AC) is responsible for defining the mission of the Oregon State University ASP3IRE
Center and providing the leadership, managerial support, and coordination that will allow the Center and its
Core Components (Cores) to achieve their specific aims and goals. The AC will support the infrastructure,
policies, and coordination required by the Core Components and the Coordinating Center so that they can
accelerate the creation, implementation, and dissemination of evidence-informed children’s environmental
health (CEH) practices, programming, and policies that produce positive, equitable, sustainable, and long-
lasting improvements in children’s health. Our AC will be innovative and foster equitable collaborations with
the scientific community and stakeholders that are trusted conduits for families and children where they live,
play, and go to school (e.g. Samaritan Health Service, Oregon Health Authority and public health agencies,
Early Learning Centers, and Extension services such as 4H Clubs, Master Gardeners, SNAP Ed, and Outdoor
School). The AC will help the Cores and Coordinating Center leverage the strength of Oregon State University
as a leading Land Grant University by identifying opportunities to incorporate children’s environmental health
research translation products into existing family and children-focused extension programs, like 4H, that are
delivered to approximately 150,000 families and children across Oregon. The AC will also collaborate with
Oregon State University Extension Service leadership, Cores, and Coordinating Center to facilitate the
dissemination of effective children’s environmental health research translation products through their
extension network which reaches into every county in the United States. The AC will also sponsor
interdisciplinary events, workshops, conferences, and scholars to advance career development in the field of
children’s environmental health research translation that promote diversity, equity, and inclusion. Finally, the
AC will facilitate the dissemination of evidence-informed children’s environmental health products to the
broader community using a variety of online strategies. Subsequently, the AC is poised to manage the ASP3IRE
Center and act as a leader among the NIEHS Collaborative Centers in Children's Environmental Health
Research and Translation.